Feasibility study of a novel NK and CD8 T cells stimulating agent

Abstract
Cell-based therapies, whether NK or T cell-based therapies, have demonstrated great efficacy in treating
hematological malignancies in the clinic. To date, there are at least seven CAR-T based therapies, including four
CD19CAR-T and two BCMA CAR-T, have been approved for treating hematological malignancies. These
successes brough excitement and promises to use cell-based therapy treating solid tumors. Currently, there are
over 300 CD8T-cell based therapy and over 150 NK cell-based for solid tumors in clinical trials, but the outcomes
from completed studies are disappointing. The foremost common challenges of T and NK cell-based therapy for
solid tumors is persistence and sustained function of infused cells in solid tumors. Two factors could contribute
to this problem: 1) solid immune suppressive tumor microenvironment; 2) over-stimulation of NK or CD8 T cells
during ex vivo expansion to drive cells to a terminal differentiation status. To circumvent these challenges, we
have discovered a new complex molecule composed of a soluble peptide and its conformational binding agent
that can be used as an additive during NK and antigen-specific CD8 T cell expansion to enable their superior
efficacy in treating solid tumors. We understood that complex programming can induce polyfunctional
heterogenic subpopulations with enriched cell pool of TCF1+ stemlike NK and CD8 T cells, in addition to
upregulating the expression of key effector molecules in respective effector cell subsets. However, the complex
could bring two potential challenges for IND-enabling studies and clinical use: i) the batch-to-batch consistency
in the complex formation; ii) a significantly higher cost in CMC (chemistry, manufacturing, and controls) of
producing two GMP-grade materials than a single CMC-grade reagent. These challenges will subsequently bring
difficulty in technology commercialization or Pharma partnership. To circumvent these challenges, CanCure has
designed and generated a panel of fusion proteins composed of the peptide and the binding agent. The
goal/milestone of this SBIR Phase I application is to screen this panel of fusion proteins for the best candidate
to move forward or make a GO vs. NO-GO decision with the fusion product and inform future plans. The
screening will be based on biological activity and pilot de-risking biochemical/biophysical characterizations for
the developability.

Public health relevance
Project Narrative Cell-based therapies, whether NK or T cell-based therapies, remain challenging for solid tumors. CanCure has. To circumvent these challenges, we have discovered a new complex molecule that can be used as an additive during NK and antigen-specific CD8 T cell expansion to enable their superior efficacy in treating solid tumors. The goal of this application is to select the most optimal form of the complex molecule by assaying the biological and developmental feasibility.